Macrophage-Targeted Drug Delivery Depot for Obesity and Comorbid Type 2 Diabetes

ABSTRACT
More than 42% of adults in the United States live with obesity, a condition characterized by excess body fat
primarily within adipose tissue. Obesity is a risk factor for type 2 diabetes, cardiovascular diseases, cancer,
and severe COVID-19 disease and has few widely effective non-surgical interventions. Obesity comorbidities
are believed to be triggered by chronic inflammation in adipose tissue, in part caused by infiltration of
macrophage cells (MΦs) with adipogenic phenotypes in the obese state. However, the pathogenic role of MΦs
is complicated by their diverse and antagonistic roles in adipose metabolism and homeostasis as these cells
have the capacity to promote both lipogenesis and lipolysis and promote both tissue hypertrophy and atrophy.
Previously, we showed that polysaccharide-based nanocarriers could efficiently deliver drugs to adipose MΦs
after intraperitoneal injection. We found that certain classes of these therapies potently modulate MΦ
phenotype, induce rapid body weight loss, and reverse diabetic phenotype in obese rodents without changes in
food intake. We now propose to develop an extended-release drug depot to deliver these MΦ-targeted
nanocarrier drug conjugates to adipose tissue in a translational format designed for high patient adherence.
Two primary technological products will be (1) biodegradable composite depots constructed from materials that
are efficiently and safely eliminated from the body and (2) translational imaging techniques to longitudinally
monitor drug depots in vivo.
In Aim 1, we will tune the composition, size, and shape of the depots to generate implants with translational
form factors, steady release over 6 months, and minimal foreign body response. We will also validate methods
to image and monitor depots by magnetic resonance, ultrasound, and fluorescence modalities. In Aim 2, we
will maximize drug loading and redesign the backbone of our targeted nanocarrier and drug linkers for efficient
excretion and high solubility. In Aim 3, we will determine mechanisms by which regional depots elicit systemic
physiological changes. In Aim 4, we will measure the long-term impact of lead candidate depots on preventing
or reversing obesity and obesity-induced diabetes. We will study the dependence of efficacy on sex, hormonal
status reflecting menopause, and genetic or dietary obesity origins. If successful, the drug delivery system may
provide an urgently needed non-surgical high-adherence strategy to treat patients living with obesity to safely
enhance weight loss and prevent or reverse the progression of comorbidities.

Public health relevance
NARRATIVE The obesity epidemic is one of the foremost public health challenges worldwide and is expected to significantly worsen over the coming decades. The goal of this project is to develop a patient-adherent therapeutic drug depot for individuals living with obesity to safely promote weight loss and prevent or reverse the progression of comorbidities. We propose to rationally develop a drug delivery system for administration once every 6 months that targets immune cells in adipose tissue, to develop imaging tools to monitor its biodegradation in individual subjects, and to analyze its impact on rodent models of obesity and comorbid type 2 diabetes, with particular focus on the dependence of efficacy on sex, menopause, and obesity origins of genetic predisposition or diet.